Airway epithelial cytoglobin regulates nitric oxide synthase and development of primary ciliary dyskinesia and situs inversus

PROJECT SUMMARY
One of the major causes of sino-pulmonary disease is primary ciliary dyskinesia (PCD), also called immotile cilia
syndrome. PCD is an inherited disease affecting 1 in ~20,000 individuals. More than 50 genetic variants have
been identified that are associated with immotile, dyskinetic, or aplastic cilia, and produce a similar clinical
syndrome of chronic sinusitis, bronchitis and bronchiectasis, recurrent pneumonia, infertility, and often situs
inversus (Kartagener syndrome). Exhaled nitric oxide (NO) derived from the epithelial NO synthases (NOSs) is
low in PCD patients and serves as a sensitive and specific diagnostic test for the disease. Cystic fibrosis (CF)
and acute viral infections can also lower exhaled NO levels, but the mechanism that underlies the low NO and
how this might contribute to the disease remains unknown. In our preliminary data, using knock-down
methodologies in zebrafish and mice, we report on a novel and unexpected finding: we have identified cytoglobin
as a conserved protein that is essential for developmental stage-specific NO signaling and ciliary motility,
required for the establishment of left-right patterning in the developing embryo and normal airway ciliary motility.
In this proposal we hypothesize that airway epithelial cytoglobin co-localizes with cilia and NOS as a metabolon
to regulate NOS-NO signaling and ciliary assembly and function. We further propose that cytoglobin modulation
of NOS-NO influences organ laterality development, potentially explaining the link between airway
inflammation/oxidative stress, NO production and signaling, ciliary function in PCD, and organ laterality
determination, with relevance to acute viral infection, smoking, and CF. Finally, we propose to exploit this new
discovery therapeutically, by testing drugs that activate the NOS-NO-soluble guanylate cyclase (sGC) pathway
to correct ciliary function in our zebrafish, mouse, and human airway epithelial models.
Aim 1 will explore the mechanisms of cytoglobin-dependent regulation of zebrafish, mouse, and human
NOS and cilia function. We have developed multiple mouse models, including CYGB knock-out, gain-of-
function (H81Q), and loss-of-function (K116E) mutations that affect heme ligand binding and oxidation-reduction,
and will evaluate interactions with NOS isoforms in zebrafish and mice and in human airway epithelial cell lines
from patients with PCD.
Aim 2 will test the hypothesis that therapeutic activation of the CYGB-NOS-NO-sGC signaling pathway
can restore airway epithelial ciliary function and developmental abnormalities in zebrafish, mouse, and
human models. Translational evaluation of genomic gain and loss of function and drug treatments will be
performed in human PCD airway epithelial cell cultures to identify new therapeutic approaches to improve muco-
ciliary clearance in airway disease.

Public health relevance
PROJECT NARRATIVE Primary ciliary dyskinesia (PCD) is an autosomal recessive disorder of cilia structure and function, characterized by chronic infections of the respiratory tract, male infertility, and disorders of organ laterality (situs inversus). In the current proposal we hypothesize that cytoglobin, a novel heme protein of yet unknown function, controls spatiotemporal nitric oxide (NO) levels in cilia in airway ciliated cells and during development, via interactions with NO synthases, necessary for normal ciliary function and left/right asymmetry of the heart. Our work aims to bridge a critical gap in knowledge about the role of NO signaling in normal ciliary function and the development of PCD and situs inversus, and has the potential to change our current paradigm for diagnosis and therapy of ciliopathies.